Brain Mechanisms of Avoidance: Implications for Addiction and Anxiety

Project Summary/Abstract
In spite of massive amounts of work, the neural basis of compulsive behavior in anxiety and especially
addiction remains poorly understood. Much progress has been made in recent years in understanding the
motivational role of drugs as positive incentives and rewards. Although it has long been known that aversive
motivation also plays a role in addiction, this is less clearly understood. External stimuli associated with
environmental stress or drug withdrawal are negative reinforcers that contribute to instrumental drug seeking
and consumption responses by strengthening behaviors that allow escape from and/or avoidance of the
aversive states elicited by these stimuli. Because active avoidance conditioning is based on negative
reinforcement and involves brain circuits that overlap with addiction, we argue that a detailed understanding of
the neural basis of escape/avoidance behavior will provide important information that may allow a deeper
understanding of the role of aversive states in substance abuse. While much research was conducted on the
neural basis on avoidance in the 1950s and 60s, this work fell out of favor, in part because the results did not
lead to a clear understanding of the circuitry. However, in the intervening years, the neural basis of the first
phase of avoidance, Pavlovian fear conditioning, has been elucidated in detail. This information makes it
possible to revisit the neural basis of avoidance in a new light. In particular, given that we now understand in
detail the neural mechanisms through which a neutral environmental stimulus associated with an aversive
unconditioned stimulus (US) becomes a Pavlovian conditioned stimulus (CS) that elicits aversive states, we
can now build on this information to understand the neural basis of avoidance conditioning. This is especially
true if the same stimuli used as CSs and USs (tone and shock) are used to reveal the neural mechanisms of
Pavlovian conditioning are also used in avoidance conditioning. The previously funded grant examined the
contribution of the amygdala, a key structure for Pavlovian aversive conditioning, to avoidance. In this proposal
we continue to pursue the role of the amygdala, but in addition also begin to dissect the broader circuitry
involved. Specifically, we examine the role of connections between the subareas of the amygdala and nucleus
accumbens, in the transition from Pavlovian conditioned reactions to negatively reinforced avoidant actions.
Optogenetic techniques will be used to relate activity in specific amygdalostriatal pathways to discrete stages
of avoidance learning and behavior, including precise negative reinforcement events (i.e. CS-termination, US-
omission or both). Lastly, because dysfunction in nucleus accumbens endocannabinoid signaling may promote
negative reinforcement and compulsions, we will use biochemistry, pharmacology and receptor knockdowns to
examine the contribution that endocannabinoid signaling makes to negatively-reinforced avoidance responses.

Public health relevance
Project Narrative Negative reinforcement is a fundamental instrumental learning mechanism that contributes to maladaptive coping strategies in anxiety and addiction. We will use a shock-avoidance paradigm in rats to study negative reinforcement in isolation from positive reinforcement, sensitization and other effects of unnatural drug rewards. Studies will use optogenetics, local pharmacology, biochemistry and receptor knockdowns to identify specific amygdalostriatal pathways that mediate precise negative-reinforcement events and are modulated by endocannabinoid signaling.